Task C20: Therapeutic Studies for Lyme Disease

The Non-clinical Services for Development of Interventional Agents for Infectious Diseases program provides services to facilitate preclinical product development of promising therapeutics for infectious disease-causing pathogens and/or toxins, including chemistry and GMP manufacturing.